Concurrent TNF-alpha and TGF-beta Impairment to Limit Radiotherapy-Induced Pulmonary Fibrosis

PROJECT 1 ABSTRACT
Ionizing radiation (IR) is used extensively to treat lung cancer, but IR can damage healthy lung tissue, causing
radiation-induced lung injury (RILI). When unmitigated, RILI leads to radiation-induced lung fibrosis (RILF). RILF
causes deterioration of pulmonary function and respiratory failure, and upwards of 30% of patients develop RILF
as a complication to radiotherapy. Investigation into treatments to block or mitigate the manifestation of RILF is
of significant importance to limit chronic lung injury following radiotherapy. Despite progress in recent years,
countermeasures to effectively combat or prevent RILF do not exist in the clinic, which represents a significant
deficiency to treat the long-term effects of IR. This deficiency is becoming even more significant because
immunotherapy, which is rapidly being incorporated into many standard chemo- and radiotherapy regimens, may
also induce and exacerbate pulmonary fibrosis. In response to radiation-induced cellular injuries, a
proinflammatory environment is observed in damaged tissues. In particular, elevated levels of tumor necrosis
factor alpha (TNF-α) and transforming growth factor beta (TGF-β) play key roles in chronic oxidative damage
and fibrogenesis following lung exposure to IR. Indeed, studies hindering TNF-α or TGF-β pathways ameliorate
oxidative damage, inflammation, and pulmonary fibrosis, while the actions of both of these cytokines lead to lung
fibrosis. Because of the cytokine-mediated cellular damage of TNF-α and the profibrotic effects of TGF-β, both
cytokines play a role in the development of RILF. We hypothesize that simultaneously impairing TNF-α and TGF-
β pathways will more effectively combat IR-induced damage to healthy lung tissue and provide better protection
against RILF than impairing either cytokine separately. In our laboratory, we recently developed a small-molecule
anticytokine—Tk-1—that inhibits the TGF-β receptor 1 (TGFβR1) and impairs TNF-α production by inhibiting
mitogen-activated protein kinase kinase kinase kinase 4 (MAP4K4) (IC50 = 0.001 µM [TGFβR1] and 0.005 µM
[MAP4K4]). We hypothesize that this novel anticytokine, acting synergistically to impair IR-induced cytokine
induction, will diminish proinflammatory TNF-α signaling in irradiated tissue and ameliorate TGF-β–mediated
fibrosis. We will test this hypothesis in cell and animal-based models of RILF. Completion of this proposal will
help generate the data necessary for R01-level funding and may uncover a novel clinical strategy to mitigate IR-
induced pulmonary fibrosis.